Engineering platelets for therapeutic applications

PROPOSAL SUMMARY/ABSTRACT
Scientists have uncovered the active role of platelets in the pathophysiology of cancer, rheumatoid
arthritis, Alzheimer's disease, multiple sclerosis, and infections, in addition to their vital roles in
hemostasis and cardiovascular diseases. Harnessing the multifaceted biological functions of platelets to
develop novel therapies and treatment strategies for different diseases is an exciting yet challenging task.
This is because, to develop platelet-based therapies, therapeutic agents (e.g., small molecular drugs or
biologics) generally need to be integrated with platelets and delivered to the desired locations. On one
hand, platelets are highly promising in achieving these tasks, considering their capacities in packing and
secreting molecules, communicating with and modulating other cells, and targeting and homing toward
injured or diseased tissues. However, on the other hand, platelets are difficult to engineer because of
their anucleate nature, dynamic and multifunctional states, and poorly understood endocytic
mechanisms. There is thus a pressing need in finding safe and effective strategies for platelet engineering
to unleash their therapeutic potential. In the next five years, our group aims to (i) perform fundamental
studies to understand how platelets interact with and internalize different synthetic materials and (ii)
develop materials-based tools for engineering platelets through either intra-platelet gene delivery or
surface modifications. Our approach emphasizes engineering polymers through architectural control. We
will evaluate how polymers with different architectures enter and deliver genes into platelets and identify
the most efficient pathways for the genetic modification of platelets using polymeric vectors. Also, as a
proof-of-concept, we will investigate to what extent the dynamic topology of polyrotaxanes can facilitate
efficient, stress-free surface binding toward resting platelets, given polyrotaxanes' self-adjustability in
orientation and distance of the carried binding ligands. The MIRA award is essential for our lab to answer
these questions through interdisciplinary approaches and train students from diverse backgrounds. We
envision that long-term research in this field will generate fundamental insights into the platelet-
biomaterials interactions and create new strategies in platelet engineering, leading new platelet therapies
for various disease indications.

Public health relevance
Project Narrative Despite the multifunctional roles of platelets in various physiological and pathological processes, their current clinical uses have been limited to preventing or stopping bleeding. This project focuses on engineering platelet different therapeutic applications through either genetic modification after intra- platelet delivery or surface decoration therapeutic agents. We expect this project will lead to new engineering strategies that can transform platelets into new cell therapies.